CMRO2 and Uncoupling of Oxidative-Phosphorylation in Experimental HIE

PROJECT SUMMARY (Description)
Optical detection of cerebral metabolic rate of oxygen (CMRO2) is a promising non-invasive method to monitor
brain injury in neonatal hypoxia-ischemia (HI), but its neuropathological correlates remain partially understood.
In this project, we will use photoacoustic microscopy (PAM) to measure CMRO2 in a murine model of HI to test
whether HI causes an overshoot of CMRO2 due to uncoupling of the mitochondrial oxidative-phosphorylation
(OXPHOS) upon reperfusion/reoxygenation, whether a secondary decline of CMRO2 signifies cerebral energy
failure and irreversible brain damage after HI, and whether hypothermia with or without antioxidants interrupts
this pathological mechanism. This project has three specific aims.
Aim 1: To test whether post-HI overshoot of CMRO2 correlates with uncoupling of the mitochondrial OXPHOS.
We will compare the changes of CMRO2, mitochondrial respirations, and cerebral energy after the HI insult in
mouse neonates.
Aim 2: To test if CMRO2 predicts the outcomes and benefits of hypothermia treatment against neonatal HI. We
will compare the changes of CMRO2 and blood levels of three candidate biomarkers (osteopontin/OPN, S100b,
UCH-L1) in HI-injured mouse neonates with and without hypothermia treatment.
Aim 3: To test whether HIF1a and antioxidants attenuates the post-HI overshoot of CMRO2 and brain damage.
We will test the effects of MitoSNO, Edaravone, and GSK360A (a HIF1a-stablizer) either as a stand-alone or
adjuvant treatment to hypothermia against neonatal HI brain injury.
Successful completion of this project will shed insights into the mechanisms and prognostic value of CMRO2 in
neonatal HI brain injury. This new knowledge may lead to better clinical managements in neonatology.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Neonatal hypoxic-ischemic encephalopathy (HIE) occurs in 3-4 per 1,000 live births in the USA and may cause grave consequences including cerebral palsy, epilepsy, and cognitive impairment, but the outcome prognostication and early detection of brain damage in these neonates remain challenges. In this project, we will use advanced imaging technology and biochemical methods to test whether the cerebral metabolic rate of oxygen (CMRO2) can serve as a bedside biomarker for HIE brain damage. Outcomes of this project will also shed insights into the mechanisms of therapeutic hypothermia and suggest novel treatments of HIE.